Mechanisms of photoreceptor outer segment assembly

Project Summary/Abstract:
In this proposal we will address one of the major unanswered questions in vision: the mechanism
of rhodopsin delivery and loading into new photoreceptor discs. This perpetual process is
particularly robust in rods where, for mammals, the daily delivery of 30 million rhodopsins supports
the formation of 80 new discs in each rod. While rhodopsin synthesis and delivery to the rod apical
region has been intensively studied, almost nothing is known about what happens afterward, thus
representing a critical knowledge gap. Roadblocks to under-standing this process include the
complexity of the inner segment-outer segment interface that is below the resolution limit of
fluorescence microscopy and the limitations of prior approaches that relied almost exclusively on
static analyses in fixed tissues. To overcome these roadblocks, we have implemented live-cell 3D
super resolution single particle tracking microscopy (3D-sptPALM) to directly examine the
dynamics of individual rhodopsins within discrete photoreceptor compartments in real time. We
will exploit a key mouse model, the retinal degeneration slow (rds) mouse, which allows us to
intentionally vary the level of outer segment membrane complexity while retaining the
photoreceptor cilium. Our preliminary results show the entry of individual rhodopsins into
photoreceptor cilia, their transport along the cilium and, remarkably, their exit back into the inner
segment, for the very first time.
We will address the following fundamental questions:
Aim 1: How does rhodopsin enter (and exit) the photoreceptor cilium?
Aim 2: How is rhodopsin transported within photoreceptor cilia?
Aim 3: How are rhodopsins loaded into new discs?

Public health relevance
Project Narrative: This work seeks to understand the molecular mechanisms of rhodopsin transport into and along the photoreceptor cilium and its loading into new outer segment disc membranes. Retinal degeneration and blindness may be caused by improper breakdown of rhodopsin delivery to new discs in the outer segments of photoreceptor, the light detecting cells in our eyes. Understanding the mechanisms by which rhodopsin is properly delivered and packed into new disc membranes will help find new therapies to extend or restore vision in patients with genetic mutations that derail this process.